Actively engaging NK cells during virotherapy to induce neoantigen-specific antitumor immunity

PROJECT SUMMARY
Significant progress in recent years on the development of oncolytic virotherapy has led to the FDA approval
of a type I herpes simplex virus (HSV-1) based oncolytic virus (Talimogene Laherparepvec or T-VEC) for the
treatment of advanced melanoma. However, it has become increasingly clear that there is a need to further
improve the current version of OV for a better clinical benefit. Our lab has constructed a HSV-2 based oncolytic
virus - FusOn-H2, the first of its kind, by a novel mechanism. Our recent studies showed that arming FusOn-
H2 with a chimeric NK engager (C-NK-E) that can engage the infiltrated natural killer (NK) cells with tumor
cells could significantly enhance the effectiveness of this virotherapy. Moreover, we observed that tumor
destruction by the joint effect of the direct oncolysis and the engaged NK cells led to a measurable elicitation
of neoantigen-specific antitumor immunity. Based on these exciting findings, we propose to develop a three-
pronged strategy to enhance the antitumor efficacy of FusOn-H2 via combinatorial immuno-oncolytic
virotherapy (IOV). The antitumor activities from this strategic three-pronged IOV come in waves in a sequential
order. The first wave comes immediately and it derives primarily from the virus-mediated direct oncolysis. The
second wave comes from the NK-mediated tumor cell killing enabled jointly by the virotherapy-trigged NK cell
infiltration and the released C-NK-E from the armed virus. The third wave is the outcome of a series of chain
events that ultimately result in induction and homing of neoantigen-specific T cells. Our major hypothesis is
that this three-pronged strategy will act in a consequential and concerted way to significantly enhance the
therapeutic efficacy of this IOV. We have designed three specific aims to test our major hypothesis. In Aim 1,
we will dissect the mechanism of C-NK-E-armed virus in generating neoantigen-specific immunity and to
design additional strategies to further potentiate this effect. Neoantigens are attractive targets for cancer
immunotherapy, but there lacks a simple and effective way of delivering them. In principle, OV offers a simple
means to release these neoantigens in individual patients, and our proposed strategy will ensure their efficient
and timely presentation to the host’s immune system without the need for additional procedures. In Aim 2, we
will investigate if combining C-NK-Es that engage two different activation receptors can further potentiate the
NK cell killing and neoantigen-specific T cell immunity. In Aim 3, we will demonstrate that the three-pronged
IOV can produce an efficient therapeutic effect against metastatic diseases by the systemic delivery route.
We have recently developed novel strategies to overcome key obstacles for systemic delivery - the rapid
clearance by the macrophage system and the neutralizing antibodies. We hypothesize that the combination
of the high potency of the three-pronged IOV with the improved systemic delivery will lead to effective
treatment of metastatic diseases. Our studies in this proposal thus overcome the two major hurdles hindering
OV - the relatively weak therapeutic activity and lack of means for effective systemic delivery, and the
developed strategy can be translated into the clinic in the near future.

Public health relevance
PROJECT NARRATIVE It has become increasingly clear that there is a need to improve the current version of oncolytic virotherapy for a better clinical benefit. We plan to develop a strategic three-pronged immune-virotherapy to overcome the two major hurdles hindering cancer virotherapy - the relatively weak therapeutic activity and lack of means for effective systemic delivery, and the developed strategy can be translated into the clinic in the near future.